Graduate Training in Developmental Biology

This is a competitive renewal for a predoctoral Training Program in developmental biology at the University of
Pennsylvania. The Training Program serves as a melting and cohesion point in developmental biology as it
includes trainers spread across four schools within the University, and students from 8 graduate groups. The
Training Program also serves as an incubator for new initiatives in graduate training that continue to be
adapted by graduate groups. The program continues to take advantage of an exceptionally strong programmatic
foundation in developmental biology at the University of Pennsylvania. The Training Program’s goal is to provide
broad-based training that uses state of the art technologies towards the fundamental mechanisms of
developmental biology using a diversity of vertebrate, invertebrate, and plant organisms. Research training areas
include transcription and cell signaling that control cell differentiation, migration, organogenesis, cellular
senescence, morphogenesis, pattern formation, epigenetic regulation of developmental processes, and stem
cell biology. Trainees receive formal instruction in an established curriculum of study, including lecture courses
in developmental biology and advanced seminars on genetic, cellular, and molecular approaches to
developmental mechanisms and disease. Students also participate in developmental biology journal clubs, a
developmental biology seminar series that includes student invited speakers, research discussion groups on
selected topics, and in annual scientific symposia. Trainees present their research findings at departmental
seminars, local symposia and national conferences. Finally, the training program provides trainee specific
activities: a) a yearly symposium to present their work in a more formal setting that includes an eminent
external speaker who evaluates the training program; b) Professional development activities, such as careers
in science meetings with invited speakers to discuss career options; mini-writing classes tailored to graduate
students covering in depth grant and manuscript writing; a mini courses in experimental design, and training
sessions with communication professionals; c) Show and Tell research days where trainees lecture other
trainees about their project followed by a hands-on demonstration of research techniques employed by the
trainee presenter, e.g. live cell imaging, d) lunchtime discussion with a Penn faculty of the trainee’s choice to
learn about the faculty’s field of research and/or to discuss lab management or career path decisions, e) a day
long visit to a pharmaceutical company to explore different aspects of working in this sector. The proposed
training program requests 8 trainees per year. Trainees will be selected annually by an ad hoc trainer committee,
and appointed for one year with the option for a second year pending satisfactory progress. Training outcomes
will be evaluated yearly by measuring trainee publications, transitions to individual training awards, trainee
surveys, an external evaluation, which all will be reviewed by an Executive Committee. Lastly, Trainers
participate in a number of efforts to recruit under-represented minorities both locally and nationally.

Public health relevance
Narrative Developmental biology is the study of how organisms self organize to produce mature life forms. It has always been an important discipline within Biology, and with the growing interest in understanding pediatric disorders and the introduction of stem cells for medical therapies, it is now more timely than ever. This broad based training program is designed to train the next generation of developmental biologists who will advance our understanding of normal developmental processes and thereby make it possible to harness the promise of stem cell therapy.